Functionally Defining HIV-Host Interactions During the Early HIV-1 Lifecycle

ABSTRACT: The early phase of the HIV lifecycle encompasses the steps from virus fusion to provirus integration
and represents a critical therapeutic target. Small molecule inhibitors of HIV encoded reverse transcriptase and
integrase are central components of many therapeutic treatment regimens and pre-exposure prophylaxis.
Despite the therapeutic importance of these steps, the field still lacks consensus on several outstanding
questions including how trafficking and uncoating are linked to reverse transcription, how and in what state the
provirus transits through the nuclear pore, what host factors are involved in these processes, and what
distinguishes between a virus that will establish successful infection and one that will fail. Due to the inefficient
and relatively stochastic nature of early phase replication, only a small percentage (~15%) of particles that enter
the cytoplasm after fusion will result in successful provirus integration. As a result, population-based assays that
measure what most viruses do may or may not actually capture what successful viruses do. Nevertheless,
technical limitations have historically mandated a reliance on population-based assays, immortalized cell line
models, and indirect measurements of biological processes whose underlying assumptions don’t necessarily
reflect the biological priors. Only recently have innovations in single-particle tracking, molecular imaging, gene
editing, and structural determination allowed for researchers to overcome these limitations, but these specialized
technologies have not yet been brought together to answer these critical questions in HIV biology. Here, we
assemble a team of HIV researchers with complementary expertise in these powerful approaches to dissect and
define the interactions, kinetics, and dynamics between fusion and integration that result in productive infection.
We propose to leverage a newly optimized toolbox of molecular labeling methods, a technique collectively
termed Infectious Virion Tracking (IVT), to image and track the behavior of individual viral components, ultimately
separating individual virions that result in successful infection from those that enter the cell non-productively.
Additional specialized technologies including primary cell CRISPR-Cas9 gene editing and cryogenic electron
microscopy will be leveraged to interrogate the structure and function of individual components along the route
to productive infection. Wielding this novel and innovative series of tools, approaches, and equipment, we aim
to: 1) Define the infectious pathway of HIV from fusion to integration in optimized cell culture models and primary
human target cells; 2) Determine the role of host permissivity factors and viral components in the processes of
the early phase of the HIV life-cycle; and 3) Visualize and define the structure of the viral based machines
associated with the HIV genome as it progresses through reverse transcription, traffics through the cytoplasm,
enters the nucleus, and ultimately integrates in the host chromosomal DNA. As a collaborative team with
complementary specialties that address critical limitations in the field, we are in a unique position to make
significant contributions to our current understanding of the early phases of HIV replication.

Public health relevance
PROJECT NARRATIVE The early phase of the HIV lifecycle is a fertile area for antiretroviral drug development as demonstrated by the reverse transcriptase and integrase inhibitors that have changed the lives of millions. We have assembled a team of established and early-stage HIV researchers with multidisciplinary expertise to address critical gaps in our understanding of how early steps in the HIV lifecycle dictate productive infection. This increased understanding should facilitate the identification of new targets and antiretrovirals to improve the lives of people living with HIV/AIDS around the world.